Effects of Preventive Dental Services and Requiring Dental Screening Certificates for School on Academic Achievement

PROJECT SUMMARY/ABSTRACT
Oral health disparities by income emerge early in life in the United States, with
disproportionately higher rates of untreated dental decay dental decay and unmet dental care
needs more among low-income children and those in Medicaid. Poor oral health is associated
with reduced school performance and lower psychosocial wellbeing. However, the extant
evidence is mostly based on contemporaneous and self-reported measures of oral health,
dental services use, and academic outcomes. Despite the conceptual relevance of preventive
dental services and the clinical evidence on their effects on oral health, there is no causal
evidence on effects of preventive dental care on academic achievement including the
magnitude of effects and their timing (at what ages effects develop and oral health interventions
are most effective over the child’s life). Policymakers recognize the links between oral health
and school health and achievement. Some states have enacted dental screening requirements
before kindergarten. However, there is no causal evidence on the effects of such policies on
dental services use and academic achievement. Adding this evidence is critically important to
guide policymaking by accounting for the full benefits of preventive oral health services and
screening programs including those accruing to school achievement. This study leverages
unique population-based dataset linking birth certificates, Medicaid enrollment/claims files, and
school test scores for children enrolled in Medicaid in Iowa. The study will identify the causal
effects of preventive dental services including comprehensive oral exams, prophylaxis, fluoride
application, and dental sealants on children’s academic achievement including the ages of the
children when these effects are most pronounced (based on age when dental services are
received and on school age when academic achievement is measured). Examining the timing
of effects is critical to identifying developmentally sensitive ages when these services become
more effective. The study will also identify the causal effects of requiring a dental screening
certificate before kindergarten on subsequent dental services utilization and academic
achievement. The study will address key gaps in the literature and provide evidence of direct
implications for policymaking aiming at addressing the adverse impacts of poor oral health on
the children’s academic performance and overall wellbeing.

Public health relevance
PROJECT NARRATIVE The study will provide evidence on how preventive dental services affect children’s academic achievement and identify if there are childhood ages that are most sensitive to receiving these services. Also, the study will evaluate the effects of requiring dental screening certificates before kindergarten on dental services use and academic achievement. The evidence will be useful for guiding oral health policymaking and understanding how oral health assessment and screening programs benefit children and if there are ages when they are more effective.